DNTP Research Involving AIDS/HIV

Specific Aims: Aim 1 is to acquire and establish use the Axion MaestroPro instrument to establish medium throughput cardiac bioactive screening library for cardiovascular bioactive drugs and test substances. Aim 2 is to evaluate the potential cardiac toxicity of a specific cART following early life exposure antiretroviral therapy. Keywords: HIV/AIDS, Human immunodeficiency virus infection, acquired immune deficiency syndrome, primary HIV, acute retroviral syndrome, asymptomatic HIV, chronic HIV, Anti-retroviral drugs; combination therapy, cardiovascular toxicity, electrophysiology, heart, cardiomyocytes, chemical screening, mitochondria, contractility, microelectrode